IGF::OT::IGF To develop HemoDefend, hemocompatible, highly porous polymer beads optimized to broadly remove freehemoglobin, potassium, reactive antibodies, and inflammatory or reactive substances from

To develop HemoDefend, hemocompatible, highly porous polymer beads optimized to broadly remove free hemoglobin, potassium, reactive antibodies, and inflammatory or reactive substances